A Technique for Measuring Transcription Factor Activity

Summary Almost every division of NIH has invested heavily in understanding transcription factors (TFs). TFs are the managers of the cell, controlling everything from cell type to cellular response to stress. With their great power, it is no wonder, many human disorders (cancer, familial platelet disorder, Waardenburg syndrome, etc.) result from mutations in transcription factors. Moreover, over 75% of disease causing variants within the human genome reside in regulatory regions, which are dense with TF binding sites. Currently we can measure the location of TF binding, but binding does not equate with regulatory activity. Furthermore, binding analysis is conducted one TF at a time. What is desperately needed is a technology that is able to measure the activity of all TFs in a cell simultaneously. We have developed a novel approach, called eRNA proﬁling, that leverages enhancer RNAs to infer the activity of all TFs in a cell simultaneously. In this grant we seek to optimize our technology, making eRNA proﬁling more accurate, fast and broadly applicable.

Public health relevance
Narrative Transcription factors are important in many human diseases. When transcription factors function they produce eRNAs. We have developed a prototype technique that leverages eRNAs to infer the activity of all TF in a cell simultaneously.